Stress Regulation of Synaptic Transmission

DESCRIPTION (provided by applicant): The long-term goal of this project is to determine mechanisms by which synaptic transmission is regulated by cellular stress pathways. The motivation of this project is twofold. First, stress plays a critical role in cognitive dysfunction and neurodegeneration associated with neurodegenerative diseases. Second, although much has been learned about how cellular responses to stress can promote neuronal survival, far less is known about how these responses can regulate neuronal function. We propose to characterize the role of a stress response pathway that mediates cellular responses to oxidative stress in regulating synaptic function using C. elegans as a model system. We previously identified a new protein that is conserved in vertebrates, WDR-23, in a functional genomic screen for genes required for synaptic transmission at the neuromuscular junction. We found that WDR-23 promotes the secretion of neurotransmitter from presynaptic terminals by antagonizing the activity of the transcription factor SKN-1. SKN-1 is the ortholog of the mammalian NF-E2 related factor (Nrf) family of transcription factors, which are critical for protecting neurons form the neurodegenerative effects of oxidative stress. We found that skn-1 activity is required for proper neurotransmission and for expression of a neuron-specific gene, acr-2, which encodes an acetylcholine receptor subunit of unknown function. Here we propose to test the hypothesis that SKN-1 regulates synaptic transmission in response to stress. First, we will determine how SKN-1 activity is negatively regulated by WDR-23 and by stress pathways in neurons. Second, we will identify the environmental and cellular stress pathways that activate SKN-1 in neurons. Third, we will determine how SKN-1-activated transcriptional programs generate changes in neurotransmitter secretion and synaptic function. These experiments will provide insights into the molecular mechanisms by which the SKN-1/Nrf stress response pathway regulates synaptic function. In summary, this work will establish a novel role for SKN-1/Nrf-mediated transcriptional programs in regulating synaptic transmission, and should provide insights into how stress impacts synaptic dysfunction associated with neurodegenerative diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: Many neurodegenerative disorders, such as Alzheimer's and Parkinson's disease are thought to be caused by toxins that accumulate in brain cells as the result of normal ageing. Here we propose to study how a natural system that the body uses to remove these toxins can impact normal brain cell function, and how it can be used to delay or prevent the onset of these diseases. Project Narrative: Many neurodegenerative disorders, such as Alzheimer's and Parkinson's disease are thought to be caused by toxins that accumulate in brain cells as the result of normal ageing. Here we propose to study how a natural system that the body uses to remove these toxins can impact normal brain cell function, and how it can be used to delay or prevent the onset of these diseases. __SpecificAimsTextDelimiter__ Stress Regulation of Synaptic Transmission A. Specific Aims The long-term goal of this project is to determine mechanisms by which synaptic transmission is regulated by cellular stress pathways. The motivation of this project is two fold. First, stress plays a critical role in cognitive dysfunction and neurodegeneration associated with neurodegenerative diseases. Second, although much has been learned about how cellular responses to stress can promote neuronal survival, far less is known about how these responses can regulate neuronal function. We propose to characterize the role of a stress response pathway that mediates cellular responses to oxidative stress in regulating synaptic function using C. elegans as a model system. We previously identified a new protein that is conserved in vertebrates, WDR-23, in a functional genomic screen for genes required for synaptic transmission at the neuromuscular junction. We found that WDR-23 promotes the secretion of neurotransmitter from presynaptic terminals by antagonizing the activity of the transcription factor SKN-1. SKN-1 is the ortholog of the mammalian NF-E2 related factor (Nrf) family of transcription factors, which are critical for protecting neurons form the neurodegenerative effects of oxidative stress. We found that skn-1 activity is required for proper neurotransmission and for expression of a neuron-specific gene, acr-2, which encodes an acetylcholine receptor subunit of unknown function. Here we propose experiments that will establish how SKN-1 is regulated by WDR-23, how stress regulates SKN-1 activity, and how in turn SKN-1-mediated transcriptional programs regulate synaptic function. This work is significant because it establishes a novel role for SKN-1/Nrf-mediated transcriptional programs in regulating synaptic transmission, and could lead to a better understanding of how stress impacts synaptic dysfunction associated with neurodegenerative diseases. Stress WDR-23 SKN-1 acr-2 ? ? Synaptic transmission Aim 1: Regulation of SKN-1 by WDR-23 in neurons. SKN-1/Nrf activity is regulated by multiple cellular signaling pathways which control its abundance in the nucleus through regulating its expression, its degradation, and its translocation to the nucleus. Our preliminary studies show that WDR-23 negatively regulates SKN-1 activity in neurons to promote neurotransmitter secretion, but how it does so and its relationship to known SKN-1 regulatory pathways is not known. Here we will first test whether WDR-23 negatively regulates the abundance of SKN-1 in neurons. Second, we will determine what factors induce WDR-23-dependent regulation of SKN-1. Finally, we will identify the cellular compartment(s) in which SKN-1 abundance is regulated by WDR-23. These results will allow us to establish a molecular mechanism by which SKN-1 activity is antagonized by WDR-23 in neurons. Aim 2: Identification of SKN-1/Nrf-dependent stress pathways that regulate neuronal function. SKN-1/Nrf integrates multiple independent signals which combine to regulate its activity in response to environmental stress. Our preliminary results indicate that SKN-1 activity is critical for proper synaptic transmission, but the environmental and cellular signaling pathways that activate SKN-1 for this function are not known. In this aim, we conduct a series of experiments to determine whether environmental stress, changes in metabolic activity, or neuronal excitability can impact SKN-1-mediated regulation of synaptic transmission. These results will allow the identification of the cellular mechanisms that regulate synaptic transmission through SKN-1. Aim 3: Identification of SKN-1 transcriptional targets that regulate presynaptic function. How do SKN-1-regulated transcriptional programs lead to changes in presynaptic function and which presynaptic molecules are critical for carrying out these effects? Our preliminary results show that SKN-1 can regulate the expression of a neuron specific gene, acr-2, which has not been identified in previous searches for SKN-1 targets, suggesting that SKN-1 may have unique transcriptional targets in neurons. Here we use functional approaches to determine whether acr-2 can impact neuronal function and neurotransmitter secretion. In addition, we will use candidate gene approaches and large-scale unbiased strategies to identify additional SKN-1 transcriptional targets in the nervous system. Finally we will identify which genes among these are important for regulation of presynaptic function. These experiments will provide a molecular framework to understand how SKN-1-dependent transcriptional targets impact presynaptic function.